Perineuronal nets, hippocampal plasticity and autism spectrum disorder

Project Abstract
Autism spectrum disorder (ASD) is a heterogeneous condition affecting approximately 1 in 59 children in
the US. ASD is characterized by deficits in social interactions, repetitive behaviors and/or restricted
interests, and is often associated with intellectual disability. Although ASD is clearly developmental, with
diagnoses typically occurring by 2-3 years of age, most people do not outgrow the diagnosis and continue
to suffer with dysfunction in adulthood. Adults with ASD experience greater unemployment and social
isolation than their peers with other developmental disorders, strongly supporting the need for therapies
targeted to adults. A few studies have reported improvements in symptoms of ASD patients with
interventions in adulthood, raising the possibility that plastic processes in the adult ASD brain may be
enhanced to optimize function. Many brain regions have been implicated in ASD but among them the
hippocampus is notable in that it is involved in both social and cognitive behavior and displays ongoing
plasticity throughout life. Perineuronal nets (PNNs) are extracellular matrix structures that dampen
plasticity and have been linked to neuropsychiatric disease. Studies have found evidence for mutations
in genes associated with the extracellular matrix in ASD but previous work has not investigated whether
PNNs contribute to social and cognitive dysfunction. Research indicates that PNNs and orthodenticle
homeobox 2 (OTX2), a transcription factor important for PNN maintenance, are excessive in ASD mice
in the hippocampal CA2 and CA3 regions, areas important for social and contextual/spatial processing.
No studies have investigated whether interventions that normalize PNNs and OTX2 in the hippocampus
mitigate problematic behaviors associated with ASD. Previous work suggests that ASD mice have
reduced postnatal neurogenesis in the hippocampus and since adult-generated neurons contribute to
social behavior as well as learning and memory, diminished adult neurogenesis may exacerbate ASD
symptoms. Many target sites of new neurons in the hippocampus are surrounded by PNNs and since
PNNs are known to inhibit plasticity, their over production in ASD may prevent optimal connections from
forming. This proposal will address gaps in our understanding about how aberrant PNNs and their
connections with adult-generated neurons contribute to behavioral dysfunction in ASD mice. The
experiments will use transgenic and inbred ASD mouse models, manipulations of PNNs and OTX2,
retroviral labeling of new neurons, immunolabeling with confocal and electron microscopy, drug and
experiential stimulation of neurogenesis and behavioral analyses to explore the efficacy of interventions
to mitigate ASD symptoms by normalizing PNNs, reducing OTX2 and optimizing connections between
new neurons and PNN+ targets. The proposed work will advance our understanding of how structural
plasticity in the hippocampus may be enhanced in the service of improving social and cognitive
dysfunction in adults with ASD.

Public health relevance
Project Narrative: Unemployment and social isolation are especially high in adults with autism spectrum disorder (ASD), statistics that support the need for therapeutic interventions in adulthood. The experiments in this proposal will investigate whether enhancing plasticity in the hippocampus of ASD mouse models by reducing perineuronal nets, enhancing neurogenesis and optimizing the formation of new connections lessens social and cognitive dysfunction in adulthood.